Cardiac MRI for Reperfusion Spatial Mapping to Improve Heart Failure Outcomes

Project Summary
Heart failure secondary to acute myocardial infarction (AMI) remains the leading cause of death and disability.
As a societal cost burden, heart failure care will be nearing $160 billion by 2030. Although emergent strategies
to re-establish coronary blood flow have substantially improved mortality, morbidity remains high. Paradoxically,
successful reperfusion may contribute to unintended microvascular injury with subsequent intramyocardial
hemorrhage. In 40-50% of patients with ST-elevation myocardial infarction, intramyocardial hemorrhage can
occur, leading to adverse effects on the myocardial microstructure. Significant structure-function consequences
include persistent cardiac dysfunction, fatal arrhythmias, and heart failure. Of the panoply of imaging biomarkers,
intramyocardial hemorrhage and the left ventricular ejection fraction (a marker of cardiac function) have the
strongest predictive value for poor cardiovascular outcomes including heart failure. Cardiac magnetic resonance
(CMR) offers high spatial resolution and is the preferred modality for the characterization of post-infarct
myocardial tissue heterogeneity. However, current CMR approaches to detect myocardial bleeding lack
sensitivity and specificity whereas methods to simultaneously detect myocardial bleeding and provide cardiac
function assessment in a single fast scan are lacking. We propose to develop a fast, free-breathing, whole-heart
cine CMR framework that employs a pure intravascular tracer to track and spatially demarcate acute myocardial
bleeding while simultaneously providing information about cardiac function. We will rigorously test our technique
in swine models and patients with hemorrhagic AMI by sampling from a large and diverse patient pool. We will
integrate high-quality, multiscale, multidimensional data to construct a patient-adaptive disease model for the
prediction of post-AMI adverse remodeling and heart failure. We expect our proposed approach to spur
therapeutic innovations for the management of hemorrhagic transformation as a complementary pathway for
mitigating downstream heart failure. Examples may include controlled reperfusion or adjunctive therapy during
interventions. Successful completion of our proposed work will shift the focus from delayed detection of
hemoglobin degradation metabolites to early simultaneous depiction of intramyocardial hemorrhage and
quantification of cardiac function. Our findings will provide a foundation for further development of a patient-
adaptive, image-guided approach based on structure-function relationships to improve heart failure outcomes.

Public health relevance
PROJECT NARRATIVE Bleeding into the heart muscles (myocardium), termed myocardial hemorrhage, is a side-effect of standardized interventions to re-establish blood flow to the heart; myocardial hemorrhage occurs in 50% of acute myocardial infarction and contributes to heart failure complications. This bleeding, however, cannot be easily detected in the acute setting by existing imaging technology; in essence, we cannot treat what we are unable to diagnose and monitor. Successful development of a reliable, quantitative cardiac magnetic resonance imaging technique to spatially track acute myocardial bleeding and creation of a patient-adaptive disease model based on structure-function relationships will provide a new path for tailoring therapy and improving heart failure outcomes.